Leveraging a natural experiment to identify the effects of VA community care programs on health care quality, equity, and Veteran experiences

Background: The Veterans Choice Program and MISSION Act have transformed how VA delivers care by
expanding Veterans’ eligibility to receive VA-funded care from community providers. The effects of this change
on the quality and equity of care are unknown. Understanding these effects is critical, given the importance of
these programs to VA and the complexity of managing care for Veterans across different health systems. To
address this evidence gap, we will use a quasi-experimental regression discontinuity (RD) design and examine
outcomes in medically and socially vulnerable subgroups to determine the impact of Choice and MISSION on
quality and equity of Veterans’ health care. To further examine impacts on vulnerable groups, we will analyze
disparities in ratings of community care from VA’s Survey of Healthcare Experiences of Patients (SHEP).
Significance: This proposal addresses cross-cutting HSR&D research priorities, including evaluating the
quality and equity of care for Veterans in the context of a key legislative priority for VA: the MISSION Act. We
will examine how the effects of receiving community care, and patient experiences with community care, differ
in vulnerable populations, addressing VA priorities related to equity. The project constitutes an advancement in
the rigor of research while directly informing ongoing and high priority clinical initiatives within VA.
Innovation and Impact: Our project is innovative because it uses an RD design to provide causal evidence
about the effects of community care on the quality and equity of outpatient care and prescribing. The project is
also innovative and impactful in its attention to subpopulations of socially and medically vulnerable Veterans,
including analyses of disparities in community care patient experiences from national survey data. By working
closely with operational partners and a Veterans Advisory Board, we will impact VA policy by translating
findings into actionable recommendations to improve community care, particularly for vulnerable groups.
Specific Aims: (1) Identify the effects of receiving outpatient community care through Choice and MISSION on
quality and equity. (2) Identify the effects of community care on the quality and equity of prescribing. (3)
Compare Veterans’ experiences with community care in vulnerable and other Veteran populations.
Methodology: We will use an RD design and analyses of both administrative and VA survey data to assess
the effects of Choice (all program years) and MISSION (2019-2022) on the quality and equity of Veterans’
health care. Aims 1-2 will use a quasi-experimental RD design that compares Veterans just above vs. below
distance and travel time eligibility thresholds for VA community care in Choice and MISSION. We will study
effects of community care use on quality overall and, to evaluate implications for equity, in vulnerable
subpopulations defined by the presence of serious mental illness or substance use disorders, complex chronic
conditions, low income, and racial/ethnic minority status. Outcome variables in Aim 1 focus on outpatient
processes of care (e.g., continuity of care) and outcomes linked to care coordination (e.g., admissions for
ambulatory care-sensitive conditions). Outcome variables in Aim 2 focus on prescribing safety and quality
(e.g., drug-drug interactions), therapeutic duplication, and refill non-adherence. These analyses use VA
Corporate Data Warehouse, Planning Systems Support Group, Medicare, and Program Integrity Tool data. In
Aim 3, we will analyze national data from the VA SHEP Community Care survey (conducted among
community care recipients) to compare patient-reported experiences with community care among Veterans in
vulnerable populations vs. other Veterans. Outcome variables in Aim 3 include 5 domains of Veterans’
experiences with care coordination, provider communication, and timely access in VA community care.
Next Steps/Implementation: Through close partnerships with the Office of Community Care, Pharmacy
Benefits Management, Office of Health Equity, and a Veterans Advisory Board, we will rapidly disseminate our
findings and translate them into actionable recommendations to improve quality and equity in community care.

Public health relevance
The Veterans’ Choice Program and MISSION Act have transformed how the Department of Veterans Affairs (VA) delivers care by expanding Veterans’ eligibility to receive VA-funded care from community providers. However, there is limited evidence about how this major structural change has affected the quality and equity of health care for Veterans, or their satisfaction with care. Given the challenges of coordinating care between VA and community providers, medically and socially vulnerable Veterans may be at particular risk for adverse outcomes from care fragmentation, underscoring a need to examine the impact of these changes on equity. Our study will use innovative analytic methods to examine the effects of these programs on the quality and equity of outpatient care and prescribing in Veterans. We will also examine how patient experiences with community care differ among vulnerable Veterans. This project will provide VA with critical evidence for guiding ongoing implementation of the MISSION Act and efforts to improve community care for vulnerable Veterans.